MOLECULAR BIOLOGY OF THE PTERIN-DEPENDENT HYDROXYLASES AND ANCILLARY ENZYMES

We are studying the aromatic amino acid hydroxylases and nitric oxide synthase (which require tetrahydrobiopterin) and the enzymes responsible fo the synthesis of tetrahydrobiopterin through an integrated interdisciplinar approach. This multi-level research is uncovering protein, substrate, effector, and product interactions that are significant in normal and diseased state biology. A central element to our research is the directed mutagenesis of the cloned enzymes to elucidate the structures and specific roles of a variety of catalytic and regulatory sites.